Comparative Bioenergetics of Aging

Comparative Bioenergetics of Aging (Overall) Project Summary
Aging and energetics are inextricably intertwined. That simple, inescapable fact has been clear since the earliest
discoveries that long-lived mammal species typically expend cellular energy at a slower rate than short-lived
species, that the longevity of poikilothermic animals was inversely related to environmental temperature, hence
metabolic rate, that reduced food intake extended life and health in numerous species, and that physical activity
was health- and longevity-promoting. Knowledge about the intricate relation between energy flux and aging
continues to accumulate. At the organismal level in recent years, for instance, it was discovered that patterns of
primate longevity are linked to 24 hour metabolism, that human fat-free mass-adjusted energy expenditure
remains constant between ages 20 and 60, and that we had been seriously underestimating the energetic cost of
mammalian reproduction, which alters our understanding of the evolution of health and longevity. At a cellular
level, we are gaining greater appreciation for the heterogeneity of mitochondrial function, depending on metabolic
demand, spatial location in the cell, and cell type among other things. Cellular processes also must be integrated
and coordinated across organ systems in response to environmental conditions to ultimately determine how
energetics affect health, diseases, and longevity which is the theme of this Nathan Shock Center (NSC). The UAB
NSC has taken advantage of its unique strengths in comparative biology of aging, world-class expertise in cellular
and tissue bioenergetics, similar expertise in the dissection of whole animal energetics, an exceptionally
innovative and adept data analytics core to offer the most comprehensive, integrated energetic assessment and
analysis available anywhere from the level of cells to organisms and across species from the size of worms to
rats. In this renewal application, the scientific goals of the Center remain to (a) assist emerging scholars in further
exploring the complex quantitative links between cellular and organismal energetics, health, and longevity and
generalize their findings by model species comparisons, and (b) provide expertise, state-of-the-art
instrumentation, and methodologies in comparative energetics analysis to investigators inside and outside of
UAB. To achieve these goals, the Center will undertake these specific aims: (1) provide an integrated Center for
research, training, and outreach in comparative energetics of geroscience, specifically to facilitate the study of the
relationship between energetics from cells to organisms and later life health and longevity. Our three Research
Cores are synergistically organized to offer the most comprehensive assessment and analysis of energetics from
cells to organisms available anywhere; (2) provide a rich intellectual environment focused on comparative
energetics, health, and aging that will foster productive interactions and collaborations among both internal and
external investigators from basic aging biology and allied health- and disease-related sub-disciplines; (3) offer
assistance, resources, training, and support for new and emerging investigators from allied health- and disease-
related sub-disciplines interested in participating in the exciting field of geroscience.

Public health relevance
Project Narrative The University of Alabama at Birmingham Nathan Shock Center of Excellence in the Basic Biology of Aging will continue to provide state-of-the-art research services and education focused on whole animal as well as cell and tissue level energetics and methods for analyzing these experimental data as they pertain to lifelong health and longevity. It will also provide education and training in geroscience and energetic analyses that are understandable at levels appropriate for the general public to levels appropriate for other scientists, and even scientific specialists in allied fields.